All of Us Research Program New York Consortium

ABSTRACT. The All of Us (AoU) Research Program aims to create one of most diverse health
databases in history. To meet this ambitious goal and build upon the program’s progress, we are
proposing to create the New York Coalition, a group of academic medical centers and partners
with significant experience in engagement, recruitment, and retention of those underrepresented
in biomedical research (UBR). As part of this unique collaboration, Mount Sinai Health System
(Sinai), Weill Cornell Medicine (WCM), New York City Health+Hospitals (NYC H+H), the
Institute for Family Health (IFH) and NYU Langone (NYU) will engage diverse communities,
neighborhoods and clinical networks across New York to recruit 88,500 new participants and
retain 35,400 participants for the program through proven, effective strategies. These include the
facilitation of a diverse stakeholder engagement board, deployment of a research equity toolkit,
pilot grants for community-based organizations who want to become recruitment sites for AoU,
and the well-validated coordinator and community health worker training program used
nationwide. We also have extensive experience recruiting participants for AoU as well as many
other genomic and non-genomic studies across this partnership. Together, we will leverage years
of long-standing collaboration to develop coordinated engagement, recruitment, and retention
strategies to partner with underrepresented populations across NYC and significantly contribute
to the success of AoU.

Public health relevance
The AoURP at Mount Sinai contributes data from participants to a dataset that researchers could use to advance precision medicine, study diseases, and determine effective treatments. In the long term, data and insights from the AoURP may be used to determine new approaches for preventing disease.